Renin as a Predictive and Prognostic Biomarker in Sepsis-Induced Hypotension

PROJECT SUMMARY/ABSTRACT
Sepsis, the syndrome of life-threatening organ dysfunction caused by a dysregulated host response to
infection, is a leading cause of death worldwide. A major factor implicated in the failure of sepsis trials is the
substantial heterogeneity in clinical presentation and underlying pathophysiological mechanisms that
characterize the syndrome, which dilutes signals of efficacy in clinical trials. Identification of subphenotypes is
a promising approach to predictive enrichment to help identify which patients may respond differentially to
therapeutic interventions in sepsis. Renin, an upstream marker of the renin-angiotensin system (RAS), is a
novel biomarker of tissue perfusion that may predict the response to sepsis resuscitation strategies. In
addition, renin trajectory may define a novel sepsis subphenotype that advances beyond a static measurement
in a single time point and considers trends in plasma renin. Our overall objective is to determine if plasma renin
can function as a predictive and prognostic biomarker in sepsis-induced hypotension. Our central hypothesis
will be tested by performing a secondary analysis of the NHLBI Crystalloid Liberal or Vasopressors Early
Resuscitation in Sepsis (CLOVERS) trial, to evaluate if plasma renin as a marker of tissue perfusion is
associated with response to hemodynamic interventions (fluid liberal vs. fluid conservative), and if sustained
activation is associated with mortality. To test this hypothesis, the following specific aims are proposed: (1)
Test the ability of baseline plasma renin to serve as a predictive biomarker to guide further treatment with
intravenous fluids or vasopressor agents to reduce organ injury and mortality in patients presenting with
sepsis-induced hypotension, (2) Identify and test the ability of plasma renin trajectories to serve as a
prognostic marker of mortality in patients with sepsis-induced hypotension, and (3) In patients with sepsis-
induced hypotension, assess the association between plasma levels of renin, prorenin, and soluble (pro)renin
receptor with markers of endothelial cell dysfunction. This proposal will leverage biospecimens and clinical
data from the CLOVERS trial and is submitted in response to RFA-HL-23-018: Maximizing the Scientific Value
of the NHLBI Biologic Biospecimen Repository: Scientific Opportunities for Exploratory Research (R21). This
proposal seeks to advance resuscitation knowledge in NHLBI’s lung injury/critical care domain, where
evaluation of differences in pathobiology and in response to treatment is a main objective of NHLBI’s strategic
vision.

Public health relevance
PROJECT NARRATIVE Sepsis, a life-threatening response to infection, can result in low blood pressure and organ injury. The proposed research will test whether levels of a hormone in the blood can help doctors choose the best strategy for treating this low blood pressure while minimizing organ injury in sepsis. The findings will help personalize sepsis care by helping doctors choose treatment strategies as well as better understand a patient’s risk of having poor outcomes when they are diagnosed with sepsis.